CONSULTATION &WORKSHOP

Attended NCRR/NIH session to edit a workshop report on ~Technologies for the Future~, May 15, 1996. Consulting with various personnel on the progress/nuances of 2~PE scanning microscopy.